Special Project Analytical Track 2: NFSDX and ORAPP

PAR-20-105 Laboratory Flexible Funding Model (LFFM) (U19) Special Project Discipline Analytical Track 2: NSFDX and ORAPP Integration Division of Consolidated Laboratory Services Principal Investigator: Christopher Waggener, Ph.D. SF424: Other Project Information Project Summary: The Division of Consolidated Laboratory Services (DCLS) is the public health laboratory for the Commonwealth of Virginia and offers a wide variety of laboratory testing services for state and federal agencies, local governments and other states in support of public health, environmental protection and emergency response. The Virginia Division of Consolidated Laboratory Services (DCLS) is applying for the FDA LFFM NSFDX and ORAPP integration. DCLS will use these funds to develop a mechanism to export data from DCLS? LIMS to integrate into NSFDX. DCLS has been a part of the pilot for state laboratories and will continue to develop LIMS to meet federal needs.

Public health relevance
PAR-20-105 Laboratory Flexible Funding Model (LFFM) (U19) Special Project Discipline Analytical Track 2: NSFDX and ORAPP Integration Division of Consolidated Laboratory Services Principal Investigator: Christopher Waggener, Ph.D. SF424: Other Project Information Project Summary: The Division of Consolidated Laboratory Services (DCLS) is the public health laboratory for the Commonwealth of Virginia and offers a wide variety of laboratory testing services for state and federal agencies, local governments and other states in support of public health, environmental protection and emergency response. The Virginia Division of Consolidated Laboratory Services (DCLS) is applying for the FDA LFFM NSFDX and ORAPP integration. DCLS will use these funds to develop a mechanism to export data from DCLS’ LIMS to integrate into NSFDX. DCLS has been a part of the pilot for state laboratories and will continue to develop LIMS to meet federal needs.